NLRP3 inflammasome activation and its crosstalk with RLR signaling at the mitochondria

Project Summary
NLRP3 (NOD-Like Receptor Protein 3) is an intracellular sensor that detects a variety of stimuli including
infection and metabolic dysfunction resulting in assembly of a macromolecular signaling complex called the
inflammasome which promotes caspase-1 dependent processing of the cytokines IL-1b and IL-18 to their
bioactive forms; these cytokines in turn underlie the pathophysiology of many autoinflammatory, autoimmune,
metabolic and infectious diseases. NLRP3 is activated by a wide-range of molecules including monosodium
urate crystals, viral RNA and even bacterial pore-forming toxins, but little is known about the mechanisms by
which NLRP3 senses and elicits a response to these chemically and structurally dissimilar stimuli. We and
others have previously shown that NLRP3 associates with mitochondria upon activation. Whether this link
simply points to a requirement for a membrane platform to achieve efficient solid-phase assembly of
inflammasome signaling components or an active modulation of NLRP3 activation by mitochondrial
components or even mitochondrial proteins remains ambiguous. It is also unclear if and how interaction of
NLRP3 with mitochondria influences mitochondrial functions. We have previously shown that NLRP3
mitochondrial recruitment and the ensuing inflammasome response is dependent on interaction of a short N-
terminal sequence in NLRP3 with the outer mitochondrial adapter protein MAVS. However, MAVS specifically
augments inflammasome assembly in response to non-crystalline, but not crystalline NLRP3 activators
suggesting an interesting and complex mechanism by which mitochondria regulate NLRP3 inflammasome
activation. In this study, we propose that additional mitochondrial proteins control NLRP3 inflammasome
activation in response to different activators, conceivably in a stimulus-specific manner. In response to
detection of RNA viruses MAVS is engaged not only by NLRP3 but also by the RIG-I- like receptors (RLRs) to
produce type 1 interferons, suggesting an unexpected crosstalk between the NLRP3 and RLR signaling
pathways. In this proposal, we will elucidate the mechanisms by which mitochondria/MAVS regulate NLRP3
activation and examine its crosstalk with the RLR pathway. This will be accomplished by: 1) mass
spectrometry to identify additional mitochondrial proteins that associate with inflammasome complexes in
response to crystals and non-crystalline NLRP3 activators, followed by assays to evaluate their effect on
inflammasome activation and mitochondrial functions, 2) soft X-ray tomography and correlative fluorescence
microscopy to assess a requirement for subcellular membrane platforms in inflammasome assembly, and 3)
models of viral infection to identify the physiological consequences of MAVS-dependent crosstalk between the
NLRP3 and RLR pathways. These investigations will yield important mechanistic insights into how
mitochondria and MAVS regulate NLRP3 inflammasome activation, which may be of relevance for modulation
of NLRP3 activity not only in viral infections but also in a variety of metabolic diseases.

Public health relevance
Project Narrative The NLRP3 inflammasome is an important mediator of inflammation in a variety of metabolic and infectious diseases but the mechanisms of its activation remain unresolved. Mitochondrial association is an important feature of NLRP3 activation but how these bioenergetic organelles regulate NLRP3 activation is an intricate puzzle. This proposal will thoroughly dissect the role of mitochondrial structures and their associated proteins in NLRP3 inflammasome activation and identify how this key organelle controls NLRP3 crosstalk with the RNA virus-sensing RLR signalling pathway, thereby yielding critical mechanistic insights into how mitochondria regulate not only inflammasome activity but also other innate sensing pathways converging on the mitochondria.